Promoting Motivation: Intervention for Alcohol Cessation in Alcohol Liver Disease

Project Summary: Alcohol Associated Liver Disease (ALD) is one of the most common types of liver disease
in the US accounting for 50,000 deaths and 30% of all liver transplants each year. Successful treatment of
ALD requires abstinence from alcohol. However, following a hospitalization for ALD rates of return to alcohol
use are high and drinking is the strongest predictor of readmission and mortality.
Few addiction interventions for ALD patients have been investigated and, notably, all rely on standard
addiction treatments that are largely not accepted by non-treatment seeking ALD patients. To address the gaps
in ALD patient care we propose an innovative addiction treatment approach to their post-hospitalization
management. Motivational Interviewing (MI) is a widely used, evidence-based therapeutic technique to elicit
positive change talk (i.e., concerning their own reasons for wanting to change their behavior; considered the
active ingredient of MI) in order to improve insight into their addiction and promote abstinence and treatment
engagement. While MI can initiate the motivation and intention for change, without ongoing re-enforcement
these effects wane over time. We will refine and pilot an innovative Motivational Interviewing Video
Reinforcement intervention (MIVR) to extend the impact of a single MI session using video clips of the patient’s
self-generated positive change talk from that session. Providing a library of personalized, on demand videos
provides ongoing access to a video reinforcement intervention of their own self-endorsed reasons not to drink.
This reminds the patient of themselves during a period of high motivation to promote self-awareness and
insight that will leverage initially heightened, and then bolster flagging motivation for abstinence over time.
We propose a two-stage project. In Stage I we will use qualitative methods iteratively within a user-
centered design approach to further refine our intervention. In Stage II, we will evaluate the final version of the
intervention in a 6-month randomized controlled trial (RCT) of 50 ALD patients who either receive an MI
session focused on abstinence followed by on-demand MI videos (MIVR) (n=25) or an MI session focused on
abstinence followed by access to public health message video clips (Enhanced Usual Care-EUC)(n=25).
MIVR and EUC groups will be asked to view their video clips weekly. Using standardized measures at intake, 3
months, 6 months, and 12 months we will collect quantitative data on key outcomes (e.g., motivation, insight,
treatment engagement, alcohol use) and qualitative data from those assigned to MIVR. The aims of the study
are to determine usability, acceptability, and feasibility of the refined MIVR intervention for ALD patients as
measured by satisfaction, rates of viewing video clips and perceptions on use. We will also evaluate whether
the refined MIVR intervention increases motivation and treatment engagement and reduces alcohol use
compared to EUC.

Public health relevance
Project Narrative Alcohol Associated Liver Disease (ALD) is one of the most common types of liver disease in the US accounting for 50,000 deaths and 30% of all liver transplants each year. Successful treatment of ALD requires abstinence from alcohol. For patients diagnosed with ALD, we propose to study a behavioral intervention to promote engaging in treatment and achieving and sustaining abstinence from alcohol.